CHRONIC EFFECTS OF CALCIUM ANTAGONISTS ON ANTERIOR PITUITARY &GONADAL HORMONES

To test the effects of two types of calcium channel antagonists on the pituitary reproductive axis and on the calcium regulating hormones.